Clinical Research and Data Informatics Core

PROJECT SUMMARY
The Clinical Research and Data Informatics Core (CRDIC) will continue to build on the strong clinical and
informatics research infrastructure established by the COBRE-supported The Delaware Comprehensive
Sickle Cell Research Center (DE SCD COBRE). There is a tremendous need to improve the clinical and
research infrastructure for patients with sickle cell disease (SCD). As a disease of minorities, there is a
longstanding history of disparate healthcare utilization, delivery, and availability as well as access to and
participation in clinical research. The mission of this project is to establish the DE SCD COBRE as a leader in
clinical and translational science providing children and young adults with SCD the opportunity to participate in
cutting-edge research, and to ensure delivery of the highest quality care. This will be accomplished by creating
a strong clinical research support infrastructure integrated with advanced principles of data science which will
open new clinical research opportunities, enable SCD researchers in the successful conduct of impactful
research, and improve patient care for a complex and underserved patient population affected by SCD. As an
integrated clinical and informatics core, the CRDIC will have the capability to support translational clinical
projects and to assist junior researchers in overcoming complex obstacles associated with this type of work.
This core will create a centralized platform that provides all of the resources required to support SCD research
and clinical quality improvement efforts, including project management, regulatory support, guidance and
mentorship of junior investigators and expertise in data analytics and data science techniques. A
quality/outcomes team, paired with community-level support, will ensure delivery of cutting-edge, high-quality,
evidence-based, safe care to patients throughout Nemours, address barriers to care and foster adherence.
Use of a SCD-specific common data model and a scalable electronic health system-informed analytic
knowledgebase will support clinical care and facilitate cohort discovery and data reporting for research and
allow for the sharing of data across institutional boundaries. This platform will facilitate the long-term
sustainability of the DE SCD COBRE.